Point-of-care system to assess the risk of trauma-induced acute respiratory distress syndrome

PROJECT SUMMARY/ABSTRACT
Trauma-induced acute respiratory dysfunction syndrome (ARDS) is a deadly condition in which lung failure
results from a traumatic injury to another part of the body. Recently, several studies have established a link
between circulating histones and lung failure. Traumatic injuries cause a massive amount of cell death,
resulting in the release of high concentrations of histones into circulation, which can directly lead to ARDS, as
histones damage the lungs. In addition, circulating histones exacerbate exaggerated pro- and anti-
inflammatory responses that also result in damage to the lungs and other organs. Identification and
quantification of trauma-triggered circulating histones would provide an approach to assess the risk of ARDS,
which could enable life-saving therapies before a patient develops ARDS. Diagnostic solutions to provide early
detection of histones following trauma should be portable and rapid in order to assess the patient soon after
the injury occurs. Currently, however, there are no portable and rapid approaches that enable detection of
circulating histones to assess a trauma patient’s risk of developing ARDS. Our goal is to develop a diagnostic
tool that is capable of quantitatively assessing the risk of trauma-induced ARDS at the point of care. This may
include at the point of injury, in the transport vehicle to a trauma center, in the Emergency Department (ED), or
in the operating room (OR). We have invented a Portable Histone Assay Technology (PHAST) that can
quantify circulating histones directly from whole blood within 30 minutes.
.

Public health relevance
PROJECT NARRATIVE Trauma-induced acute respiratory distress syndrome (ARDS) typically results as an indirect consequence of a severe physical trauma or infection. Once ARDS develops, it is particularly difficult to reverse, making it imperative to identify trauma patients at risk of developing ARDS and to administer preventative treatments before the onset of ARDS. Our overarching goal is to develop and commercialize a diagnostic tool that is capable of quantitatively and rapidly assessing the risk of trauma-induced ARDS at the point of care.